YEAST NUCLEAR PORE COMPLEX: TRANSPORT MECHANISM

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. An understanding of how the nuclear pore complex (NPC) mediates nucleocytoplasmic exchange requires a comprehensive inventory of the molecular components of the NPC and a knowledge of how each component contributes to the overall structure of this large molecular translocation machine. Therefore, we have taken a comprehensive approach to classify all components of the yeast NPC (nucleoporins). This involved identifying all the proteins present in a highly enriched NPC fraction, determining which of these proteins were nucleoporins, and localizing each nucleoporin within the NPC. Using these data, we present a map of the molecular architecture of the yeast NPC and provide evidence for a Brownian affinity gating mechanism for nucleocytoplasmic transport. This work has been published (M.P. Rout, J.D. Aitchison, A. Suprapto, K. Hjertaas, Y-M. Zhao, B.T. Chait, J. Cell. Biol. 148 (2000) 635-651)and M.P. Rout, J.D. Aitchison, M.O. Magnasco, B.T. Chait, Trends Cell Biology 13(2003)622-628. We are currently testing our model for nuclear transport using three different approaches: in vivo measurements of transport kinetics;production of an artificial NPC;and physics-based modeling of the gating/transport processes. All materials enter or exit the cell nucleus through nuclear pore complexes (NPCs), efficient transport devices that combine high selectivity and throughput. NPC-associated proteins containing phenylalanine[unreadable]glycine repeats (FG nups) have large, flexible, unstructured proteinaceous regions, and line the NPC. A central feature of NPC-mediated transport is the binding of cargo-carrying soluble transport factors to the unstructured regions of FG nups. Here, we model the dynamics of nucleocytoplasmic transport as diffusion in an effective potential resulting from the interaction of the transport factors with the flexible FG nups, using a minimal number of assumptions consistent with the most well-established structural and functional properties of NPC transport. We discuss how specific binding of transport factors to the FG nups facilitates transport, and how this binding and competition between transport factors and other macromolecules for binding sites and space inside the NPC accounts for the high selectivity of transport. We also account for why transport is relatively insensitive to changes in the number and distribution of FG nups in the NPC, providing an explanation for recent experiments where up to half the total mass of the FG nups has been deleted without abolishing transport. Our results suggest strategies for the creation of artificial nanomolecular sorting devices. A manuscript describing this work has been published: A. Zilman, S. Di Talia, T. Jovanovic-Talisman, B.T. Chait, M.P. Rout, M.O. Magnasco "Enhancement of transport selectivity through nano-channels by non-specific competition", PLoS Computational Biology. 6 (2010) e100804.